Biological Effects and Mechanistic Actions of the Natural Disaccharide and Dietary Supplement, Trehalose.

Trehalose is a widely consumed, naturally-occurring biopharmaceutical and dietary supplement, which is widely purported to have health-promoting effects in retinal, neurodegenerative, vascular and metabolic disease. The mechanism of action of this promising phytochemical and disaccharide, however, remains incompletely understood. Understanding how trehalose exerts its therapeutic and preventive effects is important because it allows patients and clinicians to best predict the optimal contexts in which it should be deployed. Moreover, because we demonstrated that trehalose appears to act through broad, fasting-like, networked mechanisms to mitigate metabolic disease, dissecting fundamental actions of trehalose promises to inform next-generation compounds that leverage these same mechanisms, and to illuminate basic aspects underlying the therapeutic effects of adaptive fasting itself. Indeed the adaptive hepatic fasting response is gaining traction as a therapeutic target against non-alcoholic fatty liver disease (NAFLD), which afflicts approximately one billion individuals worldwide. Our long-term goal is to understand adaptive liver metabolism during fasting to produce new therapies against NAFLD. Our immediate research objective is to define the biological effects and mechanism of action of the natural compound and fasting mimetic, trehalose. Three key pieces of new data substantiate our approach: First, blocking hepatic glucose transport induces the hepatocyte glucose fasting response, and this is sufficient to convey the therapeutic effects of generalized fasting on NAFLD. Second, trehalose, is a hepatic glucose transport inhibitor that reduces diet-induced NAFLD in mice. Third, trehalose activates canonical fasting-like signaling pathways in association with its action to prevent and reverse diet-induced NAFLD. We will therefore directly test the central hypothesis that trehalose coordinately induces canonical fasting pathways to modulate hepatic metabolism. Our Specific Aims are to: 1) Define mechanistic contributions of hepatic fasting signaling and autophagy (both of which are central effector pathways of the fasting response) to the biological actions of trehalose, and 2) Delineate interactions between host and microbial trehalose catabolism, and the biological actions of trehalose. Completing these studies will: 1) illuminate basic principles of hepatic glucose fasting, 2) catalyze development of next-generation biopharmaceuticals which leverage these same fasting-like mechanisms, and 3) inform optimal contexts in which to deploy trehalose as a natural, health-promoting dietary supplement and preventative against metabolic disease.

Public health relevance
Trehalose is a widely consumed, naturally-occurring disaccharide and dietary supplement, which is widely purported to have health-promoting effects. We showed that trehalose activates pathways that mimic general caloric restriction, and reduce liver fat accumulation in response to dietary insult. In this proposal we will reconcile the extent to which dietary trehalose, the hepatic adaptive fasting response, and prevention of liver fat accumulation are interconnected. This will not only allow us to identify the optimal utility and contexts in which to deploy trehalose as a natural health supplement, but it also will inform basic tenets of caloric restriction and serve as a basis to develop more advanced supplements and drug therapies that leverage these same novel mechanisms.